Leveraging Informatics to Enhance the Obstetrics Emergency Supply Chain in Amhara, Ethiopia

Maternal mortality remains a critical public health concern, especially in Sub-Saharan Africa where the majority
of maternal mortality cases occur. To improve maternal outcomes, facilities must have the clinical capacity to
manage obstetric emergencies. This capacity begins with having the necessary medications and equipment to
identify, treat, and modify care. Currently, there is no system in place in Amhara, Ethiopia to monitor readiness
and deploying supplies in real time. The aims of this study are to investigate the barriers and bottlenecks within
Amhara’s obstetric emergency supply chain and produce a dashboard prototype and design specification
document that will track the movement of emergency supplies and monitor obstetric emergency readiness. The
study aligns with the National Institute of Nursing Research priority areas of identifying interventions to remove
barriers to health equity and promoting population health. This study will provide an electronic dashboard for
monitoring facility readiness to manage obstetric emergencies in Amhara, Ethiopia which will assist in ensuring
regional facilities are able to provide adequate obstetric care. This will ultimately improve outcomes and
decrease maternal mortality rates in the region. The Socio-technical Framework will be used to guide this
mixed-methods study. This framework supports exploration of the impact of new technology in a healthcare
system. A preliminary quantitative analysis using the Signal Functions Tracer Items and the Clinical Cascade
assessed the region’s current clinical capacity to manage obstetric emergencies. To contextualize these
findings, we will conduct 20 semi-structured interviews with individuals in the regional and the federal ministries
of health along with local health facility workers who interact with the current obstetric supply chain. The
findings from the preliminary study and Aim 1 will inform the creation of the electronic dashboard for visualizing
supply chain status. We will apply user-centered design strategies, including think-aloud protocol, to enhance
dashboard usability. End-user evaluations using the Health Information Technology Usability Scale and
heuristic evaluations with human-computer interaction experts will ensure ease of use and usefulness of the
dashboard. This study will culminate in the creation of a prototype dashboard and design specification
document that can be incorporated into Amhara’s current Integrated Pharmaceutic Logistics System to
improve readiness surveillance. This study will be supported by a diverse mentorship team and will benefit
from the vast resources available at Columbia University School of Nursing and through the Emory-Ethiopia
Partnership, which has over a decade of experience conducting research and working in Amhara. This
established relationship will aid the applicant by connecting her to potential interviewees and in-country
support. Results of this study will not only improve Amhara’s capacity to monitor obstetric emergency clinical
capacity, but it will also provide the region with the tools to enact targeted interventions to both improve and
maintain a high standard of care for mothers.

Public health relevance
PROJECT NARRATIVE To improve maternal mortality rates worldwide, healthcare facilities must have supplies to treat obstetric emergencies, and regions must have functioning supply chains to receive them. The Amhara region of Ethiopia is just one region that needs a system for emergency readiness monitoring and resource procurement to prevent a lack of essential emergency supplies. We will identify where bottlenecks occur in Amhara’s obstetric supply chain and use those findings to create a dashboard that will allow facilities to request supplies in real- time and allow regional healthcare employees to monitor individual facility’s supply levels, with the goal of incorporating this dashboard into their existing online system.